EFFECTS OF CALCIUM &VIT D3 ON BONE MIN DENSITY DURING CORTICOSTEROID TREATMENT

Corticosteriods lead to osteoporosis through a number of mechanisms including direct effects on osteoblast and osteoclast function and lowering levels of sex steroids. High dose calcium and vitamin D3 may minimize bone loss effect during corticosteriod treatment.